Mycolate-specific T cell function in human immunity to Mycobacterium tuberculosis

DESCRIPTION (provided by applicant): Mycolate-specific T cell function in human immunity to Mycobacterium tuberculosis Mycolic acids are abundant constituents of the mycobacterial cell wall whose hydrophobicity leads to the clinically-useful acid-fast smear. Mycolic acid synthesis is the target of the potent anti-mycobacterial agent Isoniazid. Whereas T cells were previously thought to solely recognize peptide antigens, CD1b-restricted human T cells recognize mycolates in vitro, raising the possibility that lipid-reactive T cells influence outcomes in human infection with Mycobacterium tuberculosis. The applicant has developed and validated CD1b tetramers for tracking lipid reactive T cells at the single cell level ex vivo and within tissues. As part of a five-year training program in the laboratory of Branch Moody MD, the applicant will use CD1b tetramers to study mycolate-specific T cells from tuberculosis patients. T cells from a small number of subjects will be analyzed in detail in order to determine CD1b-restricted, mycolate-specific T cell lineage, anti-mycobacterial properties and potential for mediating memory responses (Aim 1). Subsequent cross-sectional study of human populations with latent or active tuberculosis will allow correlation of mycolate-specific T cell frequency with prior exposure to Mycobacterium tuberculosis (Aim 2A). Functional memory of mycolate- specific T cells as measured by persistence over one year of infection will be measured retrospectively in collaboration with investigators at the KwaZulu Natal Research Institute for TB and HIV in South Africa (Aim 2B). Finally, isolation of mycolate-specific T cells from human tissues with latent or active TB infection will allow their measurement in tissues at the site of disease (Aim 2C). The low level of polymorphism of CD1b genes in comparison to MHC as well as the relative resistance of lipid biosynthetic pathways to immune selection pressure make mycolate-specific T cells attractive molecular targets for immunomodulation or vaccination. This project serves as a career development award for Dr. Kasmar whose objective is to become an investigator of human immunity to infection. Tuberculosis is an infectious disease which is transmitted by coughing. Millions of people get sick from tuberculosis every year and many die. We are studying human T cells specific for TB-lipids in order to develop new diagnostic tests and vaccines.

Public health relevance
Project narrative Tuberculosis is an infectious disease which is transmitted by coughing. Millions of people get sick from tuberculosis every year and many die. We are studying human T cells specific for TB-lipids in order to develop new diagnostic tests and vaccines. __SpecificAimsTextDelimiter__ Specific Aims ab T cells were previously thought to solely recognize peptides. Studies over the last decade show that CD1 molecules present lipid, glycolipid and lipopeptide antigens to T cells. Investigation of CD1 function during infection in vivo has been dominated by the study of one major population, CD1d-restricted Natural Killer T (NKT) cells. NKT cells have important functions that are well known to immunologists. However, they are only one part of the larger family of CD1-restricted T cells that recognize CD1a, CD1b or CD1c. Recent studies suggest that all mammals express CD1 proteins. As reviewed by the applicant, orthologs of CD1a, CD1b and CD1c are broadly conserved in evolution, despite the fact that CD1a, CD1b and CD1c are not expressed in mice [1]. The retention of CD1 gene families in nearly all mammalian species suggests that each type of CD1 protein plays a comparably significant role in immunity. However, study of the natural immunological functions of T cells recognizing CD1a, CD1b and CD1c has been strongly hampered by lack of molecular reagents that can identify fresh polyclonal T cells directly ex vivo. Working with John Altman at the NIH tetramer facility over the past 3 years, the applicant has now produced and validated CD1b tetramers that bind mycobacterial mycolates and stain antigen specific T cells. Most of the known cognate lipid ligands recognized by CD1a, CD1b or CD1c-restricted T cells are mycobacterial lipids, including glucose monomycolate and related ligands discovered in the Moody laboratory. In vitro study of T cell clones demonstrates proliferation, cytolysis and release of interferon-gamma by CD1-restricted T cells in response to lipid ligands presented by CD1. These studies raise the possibility that CD1-restricted T cells play a role in the natural in vivo host response of tuberculosis patients. However, long term clones do not represent a reliable means of determining effector function of T cells. Therefore, single cell analysis of fresh T cells from human patients should provide the first broad view of the effector functions of CD1b- restricted T cells in natural infection with Mycobacterium tuberculosis. Also, ex vivo analysis of blood and tissues is the next step prior to developing lipid antigens as the molecular targets of diagnostic tests, immunomodulation or vaccination. Due to the prior lack of single-cell detection reagents, it is unknown whether CD1b-restricted T cells function as innate or adaptive lymphocytes. Innate lymphocytes, such as CD1d-restricted NKT cells, are characterized by a semi-invariant T cell receptor (TCR), the presence of pre-formed effector molecules, rapid response after stimulation and lack of memory responses. Adaptive lymphocytes, like MHC-restricted peptide-antigen specific T cells, require instruction by dendritic cells prior to cytokine production and cytolysis. Their TCR repertoire is diverse allowing recognition of millions of antigens. Adaptive lymphocyte responses are delayed and their effects are augmented after repeated stimulation, leading to immunologic memory. Thus differences in TCR repertoire, cytokine profile, response kinetics and memory generation are critical to determining whether mycolate-specific T cells function as part of the innate or adaptive immune response. These experiments are designed to determine whether CD1b-restricted T cells function as innate or adaptive T cells and will investigate the hypothesis that: CD1-restricted T cells mediate antigen-specific immune responses in natural infection with M. tuberculosis The proposed work will be carried out in two phases. First, freshly isolated mycolate-specific T cell functions will be investigated in detail (Aim 1, years 1-3). Second, the applicant will perform population-based study of mycolate-specific T cell function in tuberculosis infection (Aim 2, years 3-5). Aim 1 Determine mycolate-specific T cell lineage, effector functions and capacity for immunologic memory A. Measure CD4, CD8, CD161, PLZF and TCR diversity to determine mycolate-specific T cell lineage B. Measure IFN-g, perforin, granulysin and related effector functions to determine anti-microbial capacity C. Characterize cell surface memory correlates by multi-color flow cytometry using CD45RA and CCR7 Aim 2 Make population-based measurement of mycolate-specific T cells in latent and active TB infection A. Correlate mycolate-specific T cell precursor frequency with TB status B. Determine mycolate-specific T cell persistence over 1 year of infection C. Isolate mycolate-specific T cells from human tissues with latent and active TB lesions